Pharmacologic thresholds for safe immunosuppression

Specific aims of this study are to measure pharmacologic effect of a model combination regimen of tacrolimus and sirolimus in children with liver transplants. Immnosuppressive effect will be measured by flow cytometric determination of intracellular cytokines in peripheral blood lymphocytes. Changes in renal plasma flow and glomerular filtration rate will be used to measure toxic effect.